Immunology Research Training Grant

ABSTRACT
Support is requested for four positions in a new training grant to continue and expand our successful
Immunology Training Program at the University of California, Irvine (UCI). We have a total of 36 mentors that
include junior, mid-level and senior training faculty comprising 14 women and 3 URM faculty. UCI immunology
researchers are working on: a) host defense and vaccine development; b) tumor immunology and
immunotherapy; c) Neurogenerative disease and microglia biology; d) chronic diseases and autoimmunity; and
d) synthetic immunology. The pool of immunology graduate students comes primarily from the Cellular and
Molecular Bology (CMB) intake program. In 2022, 101 students were accepted to CMB, including 39 URM
(38.6%), and their mean GPA was 3.86 (which was similar to 2020 and 2021). There is substantial institutional
support from the Office of Research and from the Graduate Division at UCI, which will provide full stipend and
tuition for a 5th student. Our prior T32 from 2016-2021 supported 15 students, most of whom have graduated
and are in research positions in industry or academia. Dr. Eric Pearlman is the Director of the UCI Institute for
Immunology and was the Prinicipal Investigator of the previous T32 training grant. In the current submission,
Dr. Pearlman will be PI/Director, and a new faculty recruit, Dr. Ivan Marazzi, will be co-Director. Dr. Pearlman
has extensive experience in training graduate students and running T32 grants, and Dr. Marazzi has a very
exciting and well funded research program in autoimmunity chronic neurodegenerative diseases and in
molecular virology, including influenza and COVID-19. Given the outsanding training record of faculty and the
quality of training grant elibile and URM students in the program, we fully anticipate that the UCI Immunology
training program will continue to provide outstanding educational and career opportunities for the next
generation of immunology researchers.

Public health relevance
Narrative There is continued need to train young researchers who will apply cutting-edge knowledge and interdisciplinary techniques to increase our understanding of the role of immunology and inflammation in infectious diseases, in cancer immunotherapy, and in chronic degenerative diseases such as Alzheimer’s Disease and muscular dystrophies. Following the COVID-19 pandemic, there is also an urgent need to understand protective immunity and the role of the immune system in mediating tissue damage to the lungs and disease severity. A T32 training grant will enable us to continue to provide opportunities for predoctoral students to develop expertise in multiple aspects of the immune response and support our ongoing very successful Immunology Training Program.